Role of Afadin in 3D epithelial plexus morphogenesis and beta cell mass

Project Summary
Pancreatic endocrine cells, including insulin-producing beta cells, acquire their fate in a step-wise manner during
embryonic development. Understanding and recapitulating these steps has proven essential for directed
differentiation of ES cells into beta cells. A number of academic and biopharma groups have reported improved
efficiency of beta cell generation upon shifting culture methods from 2D to 3D cultures. This observation suggests
that architecture of the cellular niche for beta cell generation is critical, however, this idea currently remains
unexplored. We previously reported that when the pancreas first emerges, the endodermal epithelium undergoes
transient stratification, followed by microlumen formation and fusion to generate a 3D network of interconnected
epithelial tubes called the pancreatic `plexus' [1]. Interestingly, recent studies demonstrate that endocrine
progenitors are born within this transient core plexus. It is unclear how the plexus architecture impacts the fate
of pancreatic progenitors, including those of endocrine lineage. Since our initial proposal, we published the
findings that Afadin is essential to pancreas morphogenesis and endocrine fate (Azizoglu et al., 2017).
Here, we propose to elucidate the cellular and molecular mechanisms by which Afadin controls epithelial
lumen formation and plexus morphogenesis.
In previous work, we generated a mutant mouse with deletion of the junctional and cytoskeletal regulator Afadin
(AfapancKO) that fails to resolve its transient plexus. Co-depletion of Afadin and RhoA (AfaRhoApancKO or
AfaRhoDKO) exhibits multiple lumen defects. Surprisingly, it also produces an increase in endocrine cell numbers,
including beta cells. RhoApancKO however, show no pancreatic defects. How Afadin and RhoA pathways interact
remains unknown. One striking observation in both AfapancKO and AfaRhoDKO is that the core plexus persists. We
propose that the progenitor pool and final endocrine mass is determined by the perdurance of the core plexus.
How this occurs is the central question of this proposal. We hypothesize that Afadin and RhoA drive epithelial
lumen morphogenesis (formation/extension/resolution) via regulation of cellular processes, such as vesicle
trafficking (Aim 1), and cell division and/or cell migration (Aim 2). Further, we hypothesize that Afadin and RhoA
control these processes by regulating cytoskeletal organization (Aim 3). Together, these processes coordinate
to build a niche propitious for generation of endocrine cells.
Completion of these studies will expand our knowledge of pancreatic development, and will lead to enhanced
strategies for generating endocrine cells, including beta cells, which may contribute to novel treatments for type
I diabetic patients.

Public health relevance
Project Narrative Progenitor, or stem cells, that give rise to insulin-producing islet cells emerge from embryonic endodermal epithelium within the pancreatic bud. This work focuses on the basic mechanisms that shape the cellular microenvironment and 3D epithelial architecture where pancreatic endocrine cells are born. We use mouse models that ablate critical regulators of epithelial development, as well as pharmacological approaches, to disrupt epithelial architecture of the pancreatic bud and ask how cell fate is affected. Understanding these basic processes will lead to novel insights into regenerative and replacement therapies for diabetes mellitus.